Relevance of polycystic ovarian morphology in the clinical evaluation of PCOS

PROJECT SUMMARY. This application represents a research supplement to the parent award, R01HD093748 Relevance of polycystic ovarian morphology in the clinical evaluation of PCOS, to promote diversity in health-related research. It aims to support the career development of a doctoral student in the area of Nutrition and Reproductive Health. The candidate will be mentored while engaging in research directly related to the parent award alongside career development activities aimed at establishing a career as an independent researcher. These include formal course work, seminars, conferences, scientific writing and communication, leadership development and training in responsible conduct of research.

Public health relevance
PROJECT NARRATIVE. The supplement request is to support parent award R01HD093748 which aims to clarify the ambiguity concerning the significance of polycystic ovarian morphology to the actual clinical spectrum polycystic ovary syndrome (PCOS) and its potentially variable etiology. The supplement will support the career development of a doctoral student with the goal of increasing diversity in the health research workforce.